Neuroimmune interactions for laryngeal sensorimotor neuropathy in postviral influenza infection

ABSTRACT
The larynx is richly innervated with nerves, forming neuroimmune niches that constitute the basis for
bidirectional interactions in mucosal defense and physiology. Idiopathic sensorimotor abnormalities of the
larynx, such as acute vocal fold paralysis and chronic hypersensitivity (chronic cough, episodic laryngospasm)
are attributed to upper respiratory tract infections with a viral etiology. However, a causal link for viral-induced
laryngeal pathophysiology remains tenuous. In this application, I will employ an established model of influenza
A virus (IAV) infection to interrogate laryngeal mucosal remodeling and map afferent/efferent neural
circuits/cells in naïve and virus infected tissues. I will investigate the central hypothesis that viral infection of the
larynx will activate neurosensory cells, remodel both afferent and efferent nerves, contributing to mucosal
inflammation and hypersensitivity. I will test this hypothesis utilizing a combination of mouse genetics, whole
tissue clearing and imaging, single-cell transcriptomics and live animal functional testing. We anticipate that
these activated neural inflammatory signals are detected via a unique population of ASCL1+ neuroendocrine
and CHAT+ cells that drive a neurosensory-immune circuit for laryngeal neuropathy. Together, these
experiments are expected to ascertain neural sensorimotor circuits and reveal neuroimmune interactions for
coordinating repair pathways following viral-induced mucosal inflammation. We expect findings will guide the
field in new directions for innovating treatments for laryngeal and vocal fold inflammatory diseases and
sensorimotor neuropathies.

Public health relevance
PROJECT NARRATIVE The larynx is richly innervated with nerves and depends on release of neuro-transmitters and -peptides for relay of signals for sensory cells and following injury, likely via neuroimmune interactions. This objective of this application is to elucidate functional roles of afferent/efferent neural circuits and cells, develop a small animal injury model of postviral vagal neuropathy and test the hypothesis that ASCL1+ neuroendocrine and CHAT+ cells drive a neurosensory-immune circuit for laryngeal neuropathy and hypersensitivity. Results will provide insight into mechanisms promoting laryngeal health and targets for clinical treatment options for neurosensory disorders and viral-related mucosal inflammation.